The Alzheimer's Disease Research Center at the University of California, Irvine

UCI ADRC Overall
Project Summary/Abstract
The central theme of the University of California, Irvine Alzheimer's Disease Research Center (UCI ADRC) is
to identify, quantify, and validate factors that influence the risk of Alzheimer's disease (AD) across the lifespan.
Given its diverse and multifactorial nature, it is critical to understand the etiology and progression of this
insidious brain disorder at multiple dimensions, including clinically and neuropathologically, and to employ
novel scientific approaches so that we can advance knowledge and better diagnose, prevent and cure the
disease. The UCI ADRC has a strong history of integrating basic, clinical, and translational science to gain
insights into AD pathogenesis and to help meet some of the goals of the National Alzheimer's Project Act.
First, our Center has a distinguished record of studying the disease in diverse patient cohorts: Uniform Data
Set (UDS) Cohort, which includes cognitively normal individuals and individuals with mild cognitive impairment
(prodromal AD); adults with Down syndrome, representing the largest genetically at-risk population for AD; and
90+, which show great disparity between AD pathology and cognitive loss and are among the oldest group of
individuals to develop AD. Together, these cohorts enable interrogation of important novel questions related to
age, susceptibility and resilience, using innovative outcomes ranging from in vivo biomarker characterization to
modern pathological outcomes such as post-mortem imaging and microglial staining. Second, the UCI ADRC
has a history of innovation that has helped advance the field; the development of the nation's first induced
pluripotent stem cell bank for AD as part of the ADRC network and our recently established Consent-to-
Contact recruitment registry are recent examples of this innovation. Third, our Center continues to evolve.
Given the expertise, productivity, and resources devoted the study of special populations at UCI, we have
initiated two Special Populations Cores, one focused on Down syndrome and one focused on the oldest old
(90+). These Cores will interact with the other cores of the ADRC to produce novel data and resources
available to ADRC investigators, including through our newly established Biomarker Core. Finally, we have
established a new Research and Education Component in this proposal, which harnesses the long-standing
passionate commitment to training the next generation of clinicians and scientists at UCI. In sum, the UCI
ADRC brings energetic and innovative multi-dimensional and multidisciplinary approaches toward addressing
the national epidemic of AD.

Public health relevance
UCI ADRC Overall Project Narrative The U.S. is in the midst of a crisis on Alzheimer's disease (AD) and Orange County California is in the epicenter as there are more people with AD living here than in 26 other states. The University of California, Irvine Alzheimer's Disease Research Center (UCI ADRC) is strategically located to have a major positive impact as we identify, quantify, and validate factors that influence the risk of AD across the lifespan. The UCI ADRC brings energetic and innovative multi-dimensional and multi-disciplinary approaches toward solving this insidious disease, contributes to several national collaborative efforts, and provides key resources to the research community, including studying special populations impacted by the disease, such as underrepresented ethnic groups, adults with Down syndrome, and the oldest-old.